The role of cognitive load on lateralized motor control processes

Project Summary/Abstract
Upper limb physical rehabilitation post stroke tends to focus mainly on remediating deficits related to motor
execution of the impaired arm. This approach can be problematic due to two major reasons: (1) efficient
movement requires both intact cognition and motor execution, and (2) previous research shows that movement
deficits depend on the side of brain damage; importantly, these deficits are present even in the “unimpaired”,
ipsilesional arm. While there is a large body of evidence on the lateralization of motor control processes,
research on lateralized cognitive processes is limited. Previous studies show that right brain damage produces
larger deficits in cognitive processes, such as working memory and action selection, than left brain damage.
Our preliminary studies examining hemisphere-specific deficits in motor execution demonstrate that ipsilesional
arm movement planning deficits in individuals with left brain damage are highly correlated with functional
independence. Surprisingly, this relationship was not found in individuals with right brain damage. Based on
our preliminary studies and prior literature, we hypothesize that increased cognitive load produces functionally
limiting deficits in the control of movement that differ based on the side of brain damage. We predict that with
increased cognitive load, movement deficits will be larger with right than left brain damage. Additionally, we
predict that functional independence will be correlated with cognitive deficits in right hemisphere damaged
individuals and with motor execution deficits in left hemisphere damaged individuals. We will utilize a novel
paradigm that integrates a cognitive challenge with an upper limb reaching task. This method provides a more
real-world design for studying how cognitive load affects functional movement compared to dual-task
paradigms that involve a cognitively-challenging task in parallel with the motor task. We will recruit 36 chronic
stroke survivors with severe hemiparesis for our studies. They will each complete two tasks on a virtual reality
motion tracking system, which are designed to assess deficits in ipsilesional arm motor execution and cognitive
aspects of movement. We will also use standardized clinical assessments of ipsilesional arm function and
functional independence. This proposal assembles an investigative team comprised of experts in cognitive
neuroscience and stroke rehabilitation to accomplish the following aims: (1) To determine whether ipsilesional
arm deficits in motor control are affected by cognitive load differently in left and right hemisphere damaged
stroke survivors with severe contralesional paresis; (2) To determine whether deficits in ipsilesional arm motor
execution and cognitive aspects of movement predict functional independence differently between left and right
hemisphere damaged stroke survivors with severe contralesional paresis. The results of these studies will be
used to develop personalized rehabilitation strategies that account for hemisphere-specific deficits in motor
control, and will be particularly useful for severely impaired stroke survivors who depend exclusively on their
ipsilesional arm to conduct activities of daily living.

Public health relevance
Project Narrative Stroke is the leading cause of serious long-term disability in the U.S., but current physical rehabilitation strategies do not account for deficits related to cognitive aspects of movement and the hemisphere-specific nature of these movement deficits. The exploratory studies described in this proposal will use a novel paradigm to determine how deficits in cognition affect movement differently depending on side of brain damage and how these differences affect functional independence in chronic stroke survivors. Successful completion of this proposal will provide a strong foundation for developing personalized physical rehabilitation strategies focused on improving both motor and cognitive deficits.